Preventing Perinatal Anxiety: Testing an Internet-delivered Intervention

Project Summary/Abstract
Anxiety disorders affect more perinatal women than any other psychiatric condition, yet they often go untreated.
Up to 10.5% of mothers experience clinically significant prenatal anxiety, and up to 16% of mothers experience
postpartum anxiety. Left untreated, perinatal anxiety is associated with significant adverse health outcomes for
both mothers and infants, such as preterm birth, impaired fetal development, low birthweight, difficulty
breastfeeding, anxiety in children, and interference with parent-infant bonding. Many mothers face economic and
geographic barriers that limit their access to mental health services. Mental health accessibility is a particular
concern for mothers who live in underserved, rural areas of the United States. Thus, there is a critical need for
accessible and efficacious interventions to decrease and prevent perinatal anxiety and related disorder
symptoms. “Preventing Postpartum Onset Distress” (P-POD; developed by Dr. Steinman) is an Internet-based,
self-guided program, designed for both mothers and their romantic partners, to reduce and prevent maternal
perinatal anxiety and related symptoms. P-POD is rooted in cognitive-behavioral theory and addresses key
postpartum anxiety risk factors including: prenatal anxiety, dysfunctional beliefs, negative interpretation biases,
and low perceived partner support. The Internet-based format of P-POD increases access to care by allowing
couples to participate in the privacy of their home. Findings from an open-trial pilot study demonstrate that P-
POD is acceptable, feasible, usable, and successfully reduces postpartum anxiety risk factors. Our research
team is now ready to build upon these promising findings with a larger-scale test of P-POD efficacy in women
(N = 100) at risk for perinatal anxiety in West Virginia, a predominantly rural state. The goal of this study is to
conduct an RCT to test the effects of P-POD compared to an anxiety education control intervention on risk factors
for postpartum anxiety (Aim 1) and mothers’ anxiety symptoms, relationships with their partners, and
relationships with their infants at 8 weeks postpartum (Aim 2). Aim 2 will also include qualitative interviews with
a purposive subsample of mothers (tentatively n = 25 per condition, based on thematic saturation), to understand
the effects of P-POD (compared to the control condition) on perinatal women’s lives and to gain insight into
mechanisms underlying differences in quantitative scores. The hypotheses are that compared to an educational
control intervention, 1) P-POD will reduce prenatal anxiety and other risk factors for postpartum anxiety during
pregnancy, and 2) result in lower maternal anxiety symptoms and improved familial relationships during the
postpartum period. The proposed project is in line with NICHD’s high priority research areas of improving the
health of women during and after pregnancy, improving pregnancy outcomes, and reducing perinatal health
disparities.

Public health relevance
Project Narrative There is a critical need for accessible and efficacious interventions to decrease perinatal anxiety and related disorder symptoms, especially in underserved, rural areas of the United States. In this project, we will conduct a randomized controlled trial of “Preventing Postpartum Onset Distress” (P-POD), an online program designed to reduce and prevent perinatal anxiety in at-risk women in the predominantly rural state of West Virginia. The proposed project is in line with NICHD’s high priority research areas of improving the health of women during and after pregnancy, improving pregnancy outcomes, and reducing perinatal health disparities.